Optofluidic biosensor using integrated waveguide spectrometer

Project Summary
Spectroscopic analysis based on a wavelength-dependent sample response is an invaluable and
ubiquitous tool in diagnostics and fundamental biomedical research. It allows for multiplex
analysis, either using continuous spectra (e.g. Raman spectroscopy) or using distinct and discrete
labels. These principles are increasingly being implemented in compact lab-on-chip settings,
including optofluidic devices in which optical and fluidic functions are integrated on the same chip.
However, miniaturization of spectrometers has been a major challenge as conventional
dispersion-based instruments scale poorly with size. Only recently, new approaches based on
photonic elements and reconstruction algorithms have started to emerge, but they have not been
used in conjunction with highly sensitive multiplex bioparticle detection.
The goal of this project is to overcome this challenge by introducing and validating a new paradigm
for multiplexed spectral bioparticle analysis on a chip. The specific objectives of this application
are to incorporate a high-performance spectrometer on an optofluidic chip to enable spectral
classification of fluorescence signals from single biological nanoparticles. Our central hypothesis
is that this can be accomplished by leveraging emerging photonic design methodologies to build
a multi-mode waveguide whose light propagation patterns can be imaged from the top. The
addition of a nanostructured metasurface will allow for guiding specific wavelengths to spatially
well separated spots for easy observation with a camera.
The objectives of this application will be accomplished by the following Specific Aims: (1)
Demonstration of detection of individual nanoparticles on integrated MMI waveguide
spectrometer that is optimized by end-to-end photonic design; (2) Design and demonstration of a
nanopatterned metasurface for spectral particle classification; and (3) Multiplex direct detection
of individual exosomes from cerebral organoid cultures.
The main innovative contributions of the proposed work are: (i) a novel waveguide-based
spectrometer that can be seamlessly integrated on a fluidic chip; (ii) end-to-end inverse photonic
design of a nanostructured metasurface for efficient and easy classification of different
wavelengths; and (iii) validation of the novel device with a multiplex fluorescence assay of
individual exosomes. The proposed work is significant because it will introduce the first high-
performance integrated spectrometer for both discrete and continuous spectral analysis in a lab-
on-chip format. Thus, this approach is suitable for both fundamental research and numerous
applications, such as Raman and fluorescence spectroscopy.

Public health relevance
Project Narrative Spectral analysis is an integral part of fundamental biomedical research as well as analytical and diagnostic methods, but has been difficult to incorporate into lab-on-chip settings with high performance. This project will overcome this challenge by development of an optofluidic chip with a multimode waveguide spectrometer section enhanced with a nanopatterned metasurface for easy classification of different wavelengths. This new approach will be validated with a multiplex fluorescence assay of individual exosomes derived from cerebral organoids.